A multi-modality approach to decode epithelial heterogeneity and function in metaplasia

1) Background, key gaps in our understanding, and important challenges to be addressed. In response to
injury, differentiated adult secretory cells in the gastrointestinal tract undergo metaplasia, or the conversion of
one cell type to another. In the pancreas, this is called `acinar to ductal metaplasia' (ADM) and it is thought to
function in tissue regeneration. The goals of our laboratory are to generate tools to understand the process of
ADM, to identify the consortium of ADM cell types that emerge, and to determine their physiological role in
tissue injury. 2) Description of recent progress by the PI. By the end of her post-doctoral work, the PI showed
that differentiated, secretory cell types, such as tuft cells, form in the pancreas in response to ADM (DelGiorno
et al. Frontiers in Physiology, 2020). Tuft cells are solitary chemosensory cells with myriad roles in mediating
inflammation. Combining RNA sequencing, electron microscopy (EM), and mouse models of disease, she
identified a functional role for tuft cells, the first description in any model of tumorigenesis (DelGiorno et al.
Gastroenterology, 2020). Using single cell RNA sequencing (scRNA-seq) and EM, she has identified the
formation of several additional secretory cell populations in ADM of unknown function, which are now being
studied in the DelGiorno laboratory. 3) Overview of future research program. We propose to continue our
work on ADM by creating a workflow combining Single cell RNA-seq and EM Analysis (SEMA) to study
epithelial heterogeneity in pancreatic injury with and without the genetic manipulation of identified cell types.
Volumetric electron microscopy (3DEM) will be used as a substrate on which to map the information provided
by scRNA-seq to reveal the spatial relationships between cells and infer the function of individual cell types
through the study of their organellar content. Our approach leverages scanning electron microscopy (SEM) to
conduct a variety of experiments on the same tissue including: [1] imaging of dehydrated whole-mount samples,
[2] wide-field “chip mapping” of large areas of ultrathin sections, and [3] large-scale serial section approaches
for 3DEM acquisition. Mapping is enhanced using correlative light and electron microscopy to assign molecular
markers identified in scRNA-seq by immunofluorescence to cells with defining characteristics in SEM (e.g.,
nuclear shape, distribution of mitochondria, etc). Our 3DEM datasets are amenable to high-throughput image
processing (e.g., segmentation, geometry processing) using machine learning and deep learning tool kits.
Together, these tools provide a novel discovery workflow, which will be applied to projects throughout our
laboratory aimed at evaluating cellular heterogeneity in ADM. Our goals for the next five years are to use this
SEMA approach to build a multi-dimensional atlas of the cellular content and spatial relationships of the
various emergent cell types in ADM. Mouse models lacking individual ADM cell subtypes will be used to
assess phenotypic effects on cellular makeup, relative positioning, and disease progression. Together, these
studies will provide invaluable insight into the role of ADM in tissue healing and regeneration in the pancreas.

Public health relevance
Technological advances in single cell RNA sequencing platforms have rapidly advanced our understanding of cellular heterogeneity within complex multicellular organ systems, however validating these data remain a major challenge. Ultrastructural electron microscopy is the gold standard for cell type identification by recognition of definitive physical features, however sample preparation and analysis are arduous and low- throughput. Our laboratory is combining these techniques with deep learning as a novel workflow to predict and confirm epithelial changes in pancreatic metaplasia to understand the processes and mechanisms underlying epithelial injury and regeneration.